Administrative Core

PROJECT SUMMARY/ABSTRACT: ADMINISTRATIVE CORE
The Native Elder Research Center (NERC) seeks support for Program Years (PY) 21-26. NERC will retain
its 3 Core components—an Administrative Core, a Research Education Component (formerly known as the
Native Investigator Development Program), and an Analysis Core. Spero M. Manson, PhD, Distinguished
Professor of Public Health and Psychiatry, Director of Centers for American Indian and Alaska Native Health
(CAIANH), Colorado Trust Chair in American Indian Health, and Associate Dean for Research, Colorado School
of Public Health, Anschutz Medical Campus, University of Colorado Denver (UCD/AMC), will continue to serve
as Principal Investigator and direct the Administrative Core. Dr. Manson, a medical anthropologist, is American
Indian (Pembina Chippewa) and nationally recognized for his research and leadership in areas directly relevant
to all aspects of this Resource Center for Minority Aging Research (RCMAR), particularly aging and health
among Native elders. Dr. Dedra Buchwald, Professor and Director, Partnerships for Native Health (P4NH),
Initiative for Research and Education in Community Health, Elson Floyd College of Medicine, Washington State
University (WSU), is a widely published expert in Native health and directs the WSU component of the
Administrative Core. Together, their leadership and staff provide direction and support, both day-to-day and long-
term, to the other Center components. The specific aims of the Administrative Core are to: 1) support the
logistical operations of each component; 2) stimulate, coordinate, and monitor activities across Cores; 3)
supervise implementation of key decisions related to the research strategy; 4) facilitate program planning and
review; and 5) sustain and expand community outreach and engagement. Towards these ends, several
committees will continue to ensure NERC/RCMAR alignment with its mission, scientific aims, and regulatory and
compliance mandates. The Executive Committee, housed in the Administrative Core, will include the PI, Core
directors, and Satellite Center leaders. It will make key strategic decisions and engage in program planning and
review on a day-to-day basis. The Administrative Core team, supervised by Dr. Manson, will be responsible for
providing the Executive Committee with the operational information necessary to formulate procedural and policy
decisions and for implementing said decisions. The External Scientific Advisory Group, managed by Dr. Manson
and supported through this core, will oversee the scientific agenda of the Center, will assess the contribution of
each of its major components to this agenda, and will conduct annual reviews of the scientific progress of the
Pilot Studies and related efforts. The Satellite Centers will contribute importantly by identifying and recruiting
early-stage investigators to apply for pilot studies and by facilitating their access to data that can inform their
work. Careful coordination of these components will ensure the successful implementation of our efforts.